Opioid Prescribing Practices and Health Outcomes among Patients with Alzheimer's Disease and Related Dementia

This study proposes a longitudinal study to assess the effects of opioid prescribing practices on outcomes of
patients with Alzheimer’s disease and related dementia (ADRD). The research is responsive to priorities
espoused by the National Plans to Address Alzheimer’s disease: Goal 2 Enhance Care Quality and Efficiency
to address care needs of ADRD patients due to co-occurring chronic conditions. Chronic pain is common in
ADRD, with 90% of affected patients relying on pharmacotherapy, such as opioids, to relieve painful
symptoms. Use of prescription opioids in ADRD has doubled over the last decade; among users, over half
used opioids chronically or concurrently with other central-nervous-system (CNS) depressant medications,
contrary to what current pain guidelines suggest. These guidelines, however, adapt evidence primarily from
younger populations or older adults with healthy cognition and whether they are suitable for ADRD patients
remains unclear. To inform treatment decisions for pain management in ADRD, there is an urgent need for
evidence on the clinical effects of existing opioid prescribing practices, considering outcomes aligned with
treatment goals. For older adults who suffer from chronic pain, there is a strong need to understand if opioids
improve or worsen cognition to help clarify inconclusive findings in the current literature. To fill these research
gaps, this proposed study will leverage nationally representative longitudinal survey and assessment data that
are linked to Medicare claims to study opioid prescribing practices on outcomes of ADRD patients residing in
communities and nursing homes. Specifically, we will examine the associations between the continuation of
chronic opioid therapy with outcomes in patients with ADRD and chronic non-cancer pain. We will also evaluate
the extent to which concurrent use of opioids with CNS drugs is associated with outcomes in patients with
ADRD receiving chronic opioid therapy. Furthermore, we will assess associations between opioid use and
changes in cognitive function among non-demented older adults who had moderate or severe pain. We will
consider a range of clinical outcomes, including pain intensity, physical and mental health, and safety
outcomes, including fall-related injuries, hospitalizations, and opioid use disorder or overdose. Our study will
provide empirical evidence on the effects of common opioid prescribing practices on health outcomes pertinent
to patients with ADRD and elucidate the role of opioids on cognition in older adults with chronic pain. Because
ADRD populations are rarely included in trials, our data will have great potential to further knowledge of the
benefits and harms of opioid treatment and inform optimal use and safe opioid prescribing in patients with
ADRD. The long-term goal of this line of research is to improve management of chronic pain in older adults,
particularly those with cognitive impairment.

Public health relevance
Project Narrative There is an increasing number of patients with Alzheimer’s disease and related dementia (ADRD) using prescription opioids chronically or concurrently with other central nervous system medications, but evidence on the clinical and safety outcomes of these common opioid prescribing practices in this fast-growing, vulnerable population is lacking. There is also a poor understanding of the role of opioids on cognition in older adults with chronic pain. The proposed research, which is responsive to the priorities of the National Plan to Address Alzheimer’s Disease, will contribute to informing optimal use and safe opioid prescribing for chronic pain that is commonly comorbid in patients with ADRD.